Leveraging the Highly Active Metabolite of Pioglitazone as a Scaffold for a Novel Non-Immunosuppressive Therapy for Childhood Nephrotic Syndrome.

Project Summary
There are no FDA-approved drugs for Childhood Nephrotic Syndrome (NS). In NS, the kidney’s podocytes are
injured, causing protein to leak into the urine. Patients typically receive steroids and must cope with the
accompanying toxic side effects that can be particularly harmful for a pediatric population: growth retardation,
delayed puberty, increased risk of infections, metabolic disruptions, mood and behavioral changes, and high
blood pressure. In the case of complicated NS where steroids are less effective, patients receive additional
immunosuppressive therapies that are only partially effective and cause additional serious side effects. The most
serious side effects from steroids and other NS treatments are due to their immunosuppressive nature. Our prior
research identified nuclear receptors of the kidney’s podocytes to be an alternative route for protecting the
podocytes from injury and restoring the urine protein levels to a normal level. Using a medicinal chemistry
approach, we designed the lead compounds in the CBP-002 program, which target a nuclear receptor agonist
to the kidney. Preliminary data shows a 4x targeting to the kidney and favorable pharmacokinetics. However,
recent evidence suggests that using the metabolite of this agonist could generate a more potent and less
clinically variable drug. Our working hypothesis is that a carefully designed prodrug of this agonist metabolite
(racemate or stereoisomer) can be targeted to preferentially accumulate in the kidney, abrogating serious side
effects while maintaining or improving efficacy. Yet, the major metabolite and its stereoisomers lack full
characterization, and it is unknown how the potential binding and functional differences will impact their
downstream effects in NS. Thus, we propose the following Specific Aims to better characterize the metabolite:
Aim 1: Perform in vitro studies of human podocytes to directly compare the protective effects of
racemate agonist metabolite and its stereoisomers vs. parent agonist, benchmarking against steroids.
Aim 2: Perform in vivo studies in a PAN NS animal model to directly compare the abilities of racemate
or stereoisomers of agonist metabolite to reduce proteinuria compared vs. parent agonist vs. steroids.
Aim 3: Compare isolated glomerular transcriptomes among PAN-NS rats with proteinuria reduction
induced by the agonist metabolite vs. parent agonist vs. steroids.
The in vitro and in vivo studies will identify which active moiety should be included in the nominated Drug
Candidate for IND-enabling studies and greatly accelerate its translation to real clinical value for children with
NS.
The team leading this effort has extensive expertise in podocyte biology, NS, and drug development in rare
kidney diseases. The team is joined by significant collaborators and consultants to successfully execute the
proposed research plan.

Public health relevance
Childhood Nephrotic Syndrome impacts 1.1-1.9 children per 100,000 and carries potentially life-threatening complications, yet has no FDA-approved drugs and standard treatment has serious side effects. We propose to leverage new understanding of the underlying biology to create a kidney-targeted, non-immunosuppressive alterative therapy. The successful development of this drug would greatly benefit children afflicted with Nephrotic Syndrome, in particular those who do not respond well to standard steroid therapy.